The Newest "Burdensome Transition"? Moving from Medicaid Expansion Coverage to Medicare at Age 65

PROJECT SUMMARY
Among the 10,000 Americans turning 65 every day, those with health insurance coverage under the Affordable
Care Act's Medicaid expansion face a unique challenge: They may lose Medicaid coverage when they
transition to Medicare as their primary insurer and face substantially higher premium and out-of-pocket costs.
This transition in insurance coverage may have deleterious effects on access to care, but there is little
published research to our knowledge about the individuals who “age out” of Medicaid expansion
coverage and transition to Medicare as their primary insurer. The long-term goal of this proposal is to
inform policies to ensure that adults with low incomes have access to comprehensive, affordable health care
whether they are nearing age 65 or are on the other side of it. The immediate objective of this research is to
understand the extent to which 64-year-old Medicaid expansion enrollees lose or retain Medicaid benefits upon
transitioning to Medicare and how this impacts their risk of hospitalization and even death. Our central
hypotheses are that many near-elderly adults with Medicaid expansion coverage do not retain full Medicaid
benefits when they turn 65, particularly in states with less generous dual eligibility criteria, and this negatively
affects their ability to access care. To evaluate our hypotheses, we will address these specific aims: 1)
Identify individual characteristics and state-level policies associated with the loss or retention of Medicaid
coverage at age 65 among individuals who had coverage through Medicaid expansion as 64-year-olds, and 2)
evaluate whether the loss of full Medicaid benefits upon transitioning to Medicare impacts acute
hospitalizations and all-cause mortality in the first year of Medicare coverage and up to three years after
transitioning. To achieve these aims, we propose to use 2014 and 2015 Medicaid enrollment and claims data
for eight large Medicaid expansion states (California, Illinois, Maryland, Massachusetts, New Jersey, New
York, Ohio, and Pennsylvania) to identify a cohort of 64-year-olds that can be linked to Medicare enrollment
and claims data through 2018. The first aim will apply a longitudinal study design to examine patterns of loss
and retention of Medicaid benefits among individuals who had Medicaid expansion coverage at age 64 and
then transitioned to Medicare at age 65. Aim 2 will apply a quasi-experimental study design to compare the
rate of acute hospitalizations and the mortality rate before and after the transition to Medicare at age 65 among
the group of Medicaid expansion enrollees who retained Medicaid when they became Medicare beneficiaries,
and among the group that lost Medicaid. This work is innovative because it will be the first study to link
Medicaid and Medicare enrollment and claims data to study this population over time. This work is significant
because it will reveal whether older adults with Medicaid expansion coverage may be worse off when they
transition to Medicare. Insights gained through this work can inform efforts to expand Medicaid eligibility to
the expansion population over age 65 and proposals to expand Medicare to individuals under age 65.

Public health relevance
PROJECT NARRATIVE This proposed research is relevant to public health because for older, low-income adults with Medicaid expansion coverage, turning 65 and gaining Medicare could mean more expensive coverage with fewer benefits. Individuals who face higher out-of-pocket costs under Medicare than they had as Medicaid expansion enrollees may skip doctor's visits or medications, increasing their risk of hospitalization or even death. This work to understand whether older adults who gain coverage under the Affordable Care Act's Medicaid expansion may be worse off when they transition to Medicare aligns with AHRQ's mission to produce evidence to make health care more accessible, equitable, and affordable, and with AHRQ's priority area to improve accessibility through understanding how changes in policy affect the health insurance landscape.